Single Cell Analysis of Cross Talk Among Kinase Pathways

Interactingcascadesof signaling proteins, particularly kinases, play crucial roles in the development and maintenance of cancer. Despite their importance inoncogenic signal transduction pathways, little is understood about the biochemical behavior of these )roteinswithin the context of the living cell. It is now clear that these signaling cascades are not merely a linear series of enzymatic [unreadable]eactions leadingfrom discrete stimuli to defined cellular responses. Rather, they are interrelated in complex networks such that their biochemical propertieswithin the living cell are not intuitive. Traditional biochemical studies that rely on lysates of bulk cell populationscannot decipher the inherent properties of cell signaling due to averaging of heterogeneous cellular responses across the population. To understandsuch biochemical phenomena as cross-talk between pathways, thresholds of activation and bistable states, kinaseassays must be performed in intact, single cells. The currentwork is directed at decoding the biochemical behaviors of the Ras-related pathways- signaling pathways of particular importto cancer biology. These studies will apply a powerful new technologyfor kinase assays in single cells to a unique series of tumor cell lines possessing contitutively active or inactive signaling proteins. The cell lines (human HT1080/MCH603 fibrosarcomaand mouse NIH3T3) display a range of tumorigenic characteristics dependent on the repertoire of constitutive activity in Ras-relatedSignalingpathways. In mass populations of MCH603 cells our data support the notion that the threshold behavior and crosstalk among these pathways closely relate to the relative aggressiveness of their tumorigenic phenotype. The current studies will reveal how the behavior of signaling cascades involving the kinases phosphoinositide-3-kinase (P13K), Akt, p21-activated kinase and Erkl/2 interrelate in living, single cells. The specific aims for this project are to 1) determinewhether induction of crosstalk, generated by P13K activity, requires a threshold level of activated P13K; 2 determine if cross-activation of these kinase pathways is coordinate or sequential; and 3) determine if cross-talk activation of MAP kinase cascades is reversible or irreversible after withdrawal of the P13K or Akt stimulus. These studies will provide additional information relating to our understanding of the consequencesof activationof kinase signaling pathwayswith respect to malignant transformation, aggressive tumor growth and survival.